Control of cell polarity and migration by non-centrosomal microtubules

Project Summary/Abstract:
The coordinated and regulated remodeling of the actin and microtubule (MT) cytoskeleton is required for cell migration
for developmental processes and homeostatic maintenance, as well as during the body’s response to external insults and
disease states including heart disease and tumor metastasis. During cell migration, actin filaments assemble and become
linked to focal adhesion (FA) complexes, while MTs undergo dynamic instability that is locally controlled by MT-
associated proteins (MAPs). These two processes enable cells to establish a leading-edge and a trailing-edge, and to
migrate with directional persistence. Despite many advances in our understanding of the functional implications of MAPs
on MTs and MT-FA interactions, it remains unknown how exactly MT organization is spatially and temporally
coordinated with FAs to promote directional cell movement. A critical discovery, that non-centrosomal MTs are both
sufficient and required to drive polarized cell migration, suggests that non-centrosomal MTs are primed to function in a
way that is distinct from MTs nucleated by the centrosome. This finding underscores the need to determine how
cytoskeletal proteins identify and regulate non-centrosomal versus centrosomal MT dynamics and effects on polarity and
migration. This gap in knowledge impacts our understanding of fundamental processes, including how signaling
molecules simultaneously regulate families of proteins to achieve complex tasks, such as guiding persistent cell migration.
The small GTPase, Rac1, is a key signaling protein that is spatially controlled to promote FA formation, MT growth, and
actin filament assembly, resulting in leading edge advance. Rac1 signaling is complemented by the molecular motor
protein, myosin-II, which organizes actin stress fibers, promotes FA maturation, and generates forces that pull the trailing-
edge of the cell forward. Thus, Rac1 and myosin-II are spatially and temporally controlled to drive directional cell
movement. We recently discovered that another family or MAPs, termed septins, respond to Rac1activity by relocating
adjacent to FAs, where septins reorient non-centrosomal MT polymerization into FAs and drive FA disassembly and
directed migration. Collectively, these findings point to functionally and spatially distinct roles for centrosomal and non-
centrosomal MT-mediated regulation of FA dynamics and directed cell motility. Here, we will test the hypothesis that
Rac1 and myosin-II promote FA-localized membrane curvature to recruit septin, that polyglutamylation of non-
centrosomal MTs promotes septin-MT interactions and FA disassembly, and that FA-tethered centrosomal MTs function
to deliver matrix remodeling cargo to FAs. Our approach will incorporate a team of undergraduate researchers using
fluorescence microscopy of live endothelial cells to determine: (1) how Rac1 signaling and actin-myosin contractility
regulate septin localization adjacent to FAs, (2) how septins functionally distinguish centrosomal MTs from non-
centrosomal MTs, and (3) whether/how centrosomal and non-centrosomal MTs work together to promote FA disassembly
and directed cell migration. These investigations will provide critical advances to the field of cell migration by
functionally linking Rac1 and myosin-II with cytoskeletal effector proteins that regulate centrosomal and non-centrosomal
MT behaviors to control FA dynamics and cell migration in health and disease.

Public health relevance
Project Narrative: Cell polarity and migration are critical life-long process required for developmental processes and homeostatic maintenance, as well as during the body’s response to external insults and disease states including wound-healing and tumor metastasis. The prior funded cycle identified a key mechanistic signaling pathway responsible for driving changes in cell architecture. The goals of the next funding cycle build upon these discoveries and new hypotheses that will determine how this signaling pathway coordinates the cellular machinery required for directed migration.